New Amination Methods and Strategies for Chemical Synthesis

Title: New Amination Methods and Strategies for Chemical Synthesis
PROJECT SUMMARY/ABSTRACT
The ubiquitous presence of nitrogen atom in small-molecule probes and drugs highlights the significance of
nitrogen-containing molecules in biomedical research and drug discovery. The broad availability of drugs is
directly dependent on the existence of cost-efficient methods that can reliably build such novel molecular
structures and uncover their biological activity and therapeutic promise. Rapid and efficient synthesis of
structurally diverse nitrogen-containing skeletons is of the utmost importance, as is the ability to understand their
biology, pharmacology and potential as chemical probes and drug candidates. Our research program aims to
establish a chemical platform that expedite the synthesis and development of novel nitrogen-containing molecule
as new probes and leads toward advancing the understanding and treatment of human disease. Toward this,
we will develop new catalytic selective amination methods and aminofunctionalization cascades that can
streamline the creation of structurally complex and richly functionalized novel nitrogen-containing molecules from
readily available starting materials, such as alkenes, dienes, cyclopropanes, and functional molecules. We will
focus on electrophilic amination strategy based on the unique and diverse reactivity of heteroatom-nitrogen
bonds––readily available yet traditionally underutilized nitrogen precursors––to design new C–N bond formation
reactions that are different but complementary to existing methods. Successful implementation of these studies
will greatly facilitate the synthesis and study of a wide range of nitrogen-containing molecules that are difficult or
impossible to access with current technologies. Lessons learned in reaction engineering for efficacy and
selectivity will be applicable to the invention and development of useful chemical processes, beyond amination
chemistry. Overall, these new abilities are highly valuable and important in organic synthesis, medicinal
chemistry, biomedical research, and drug discovery, by greatly contributing to the expansion of novel chemical
space and diversity of N-containing molecules as well as the discovery of new lead compounds and small-
molecule probes.

Public health relevance
PROJECT NARRATIVE The ubiquitous presence of nitrogen atom in small-molecule probes and drugs highlights the significance of nitrogen-containing molecules in biomedical research and drug discovery. This research project will develop new catalytic methods for regio- and stereoselective aminofunctionalization of alkenes, dienes, and cyclopropanes, especially those involving C–N bond formation cascade reactions, to advance the synthesis and study of novel nitrogen-containing molecules. Such ability to prepare structurally diverse nitrogen- containing skeletons in the most rapid and efficient way possible is of the utmost importance, as is the ability to understand their biology, pharmacology and potential as new leads and tool compounds.